Deciphering the source and consequences of Nur77 expression during E. coli rUTI in mice

ABSTRACT
Recurrent urinary tract infection (rUTI) is a costly clinical problem that affects millions of women worldwide and
contributes to the global rise in antibiotic resistance. Multiple lines of evidence indicate that bacteria in the vagina
can affect susceptibility to UTI. For example, women with the vaginal dysbiosis called bacterial vaginosis (BV)
are at increased risk of UTI. Several vaginal bacteria—including the BV-associated species Gardnerella vaginalis
(G.v.)—have been isolated from urine collected directly from the bladder by needle aspiration or transurethral
catheterization. Although culture conditions are not often poised to detect it, the presence of G.v. in urine is also
epidemiologically linked with rUTI. We have developed new mouse models to define the impact of vaginal
bacteria on UTI from a new perspective—testing the idea that transient bladder exposures to vaginal bacteria
such as G.v. influence the pathogenesis of Escherichia coli (E.c.), the leading cause of UTI. We previously
demonstrated that G.v. triggers apoptosis and exfoliation of the bladder epithelium in mice. When mice harbored
latent intracellular bladder reservoirs of E.c. from a prior experimental infection, G.v. triggered emergence of E.c.
and rUTI at a rate 4-fold higher than mice exposed to vehicle alone. These data indicate that bladder exposures
to G.v. could represent a trigger of rUTI in women.
To understand at the cellular and molecular level how G.v. triggers exfoliation and rUTI, we have examined the
transcriptional response to G.v. in the bladder using bulk RNA sequencing. This analysis revealed that G.v.
induced the expression of the orphan nuclear receptor Nur77 (also called Nr4a1). Nur77 is well-recognized for
its role in apoptosis and in inflammatory responses in diseases in other tissues, but its role in the urinary tract is
largely unstudied. Our preliminary data using Nur77-/- mice indicate that Nur77 is required for G.v. to trigger E.c.
rUTI in our mouse model. In this focused R03, we seek to answer two fundamental questions regarding the
contribution of Nur77 to G.v.-induced E.c. rUTI: Which cell types in the bladder express Nur77 following G.v.
exposure? (Aim 1), and Which host responses to G.v. exposure—exfoliation or inflammatory cytokine
production—are mediated by Nur77? (Aim 2). Our proposed experiments build upon our preliminary data and
leverage available Nur77 knockout and reporter mice and our experience in detailing bladder responses to
microbial exposures. Successful completion of these studies will provide important mechanistic insights into how
G.v. triggers E.c. rUTI and will generate key data on which to build a future R01 proposal.

Public health relevance
PROJECT NARRATIVE Recurrent urinary tract infection (rUTI) is a common and costly clinical problem, affecting millions of women in the U.S. and worldwide. We have found that the bacterium G. vaginalis triggers rUTI in wild type mice. G. vaginalis induces expression of the immediate early gene Nur77 in the bladder, and fails to trigger rUTI in mice lacking Nur77. This project seeks to understand how Nur77 affects G. vaginalis-induced rUTI.